Cardiomyocyte-specific modified mRNA of Pkm2 for induction of cardiac regeneration in ischemic heart failure

PROJECT SUMMARY
Ischemic heart failure (HF) secondary to chronic post myocardial infraction (MI), is a leading cause of death
and disability worldwide. The high morbidity and mortality rates in ischemic HF are caused, in large part, by the
low regenerative capacity (and therefore repair) of the mammalian adult heart. Several tissue-engineering, cell-
and gene-based therapies have been attempted for induction of cardiac regeneration following MI. Since
cardiomyocyte (CM) proliferation and cardiac regeneration are highly robust processes in Zebrafish and Newts,
efforts to mimic the pro-proliferative mechanisms of these lower phylogenetic organisms in the adult
mammalian heart have been attempted using standard gene therapy vectors. Those approaches however,
have encountered major challenges that are related to short-term, low, or uncontrolled delivery of the target
gene. At best, this has resulted in poor CM proliferation. In other cases, these strategies have led to highly
undesirable outcomes, including exacerbation of pathological hypertrophy and inflammation. We have recently
shown that modified mRNA (modRNA) delivery is a safe, efficient, transient, non-immunogenic, local, and
dose-controlled cardiac gene delivery platform. We have found that the glycolytic enzyme Pyruvate Kinase
Muscle Isozyme M2 (Pkm2), which is highly expressed in regenerative fetal and neonatal CMs but not in adult
CMs is an effective vehicle for re-awakening cardiac regeneration when delivered at the time of MI. Selective
Pkm2 modRNA delivery to distinct cell populations led to a significant increase in their respective rates of
proliferation. Proliferation of non-CMs such as myofibroblasts may exacerbate pathological remodeling by
impairing diastolic function, disrupting myocardial conduction, and promoting arrhythmias. To circumvent this,
we have designed a unique CM-specific modRNA-based approach for improving post-MI cardiac repair and
regeneration. This proposal will identify the optimal therapeutic widow for modRNA-mediated delivery of Pkm2
to CMs following the phase of active healing for effective reversal of electro-mechanical dysfunction, will
determine the molecular mechanisms by which local and transient delivery of Pkm2 promotes CM proliferation
via β-catenin and downstream signaling, and finally determine the altered conduction properties and risk of
arrhythmias associated with efficient integration of newly-formed Pkm2-dependent CMs with the host
myocardium post MI. The highly translatable nature of our proposed modRNA platform and our integrative,
multi-disciplinary experimental plan are ultimately geared towards clinical applicability for ischemic heart
failure.

Public health relevance
PROJECT NARRATIVE Myocardial regeneration as a repair mechanism for acute myocardial infarction is critically dependent on proliferation of cardiomyocytes- a process that is essentially silenced in the adult heart. Our current proposal focuses on using modified mRNA based delivery of a key glycolytic enzyme (Pkm2) for selectively reawakening the proliferative capacity of CMs at a critical time-window during the remodeling process. The project will explore the utility of this approach for reversal of chronic post-MI heart failure (Aim 1), uncover the signaling pathways and electrophysiological of Pkm2-derived CMs in MI model (Aim 2 and 3).